CAMELLIA Cohort: A longitudinal study to understand sexual health and prevention among women in Alabama

Abstract
Despite the availability of effective HIV prevention tools such as pre-exposure prophylaxis (PrEP), significant
disparities persist among communities of color, particularly among women in the Deep South where the rate of
HIV infection is fourteen-times higher for Black women compared to White women. PrEP utilization remains
low among women in the Deep South with estimates of <7% eligible women receiving PrEP in Alabama.
Moreover, algorithms to determine PrEP eligibility demonstrate poor predictive power for women. The proposal
takes advantage of a dynamic and innovative collaboration of experienced HIV-prevention investigators from
the University of Alabama-Birmingham, University of North Carolina-Chapel Hill, Centers for AIDS Research,
the Alabama Department of Public Health (ADPH), and Social Scientific Systems. This novel research
proposal utilizes a population-based approach to establish a geographically representative cohort of cis- and
trans-gender women (‘Camellia Cohort’) at significant risk for future HIV acquisition, based on recent
gonorrhea or syphilis infection, across the state of Alabama (AL), highlighted as a geographic hotspot by the
federal Ending the HIV Epidemic strategy, to better understand factors associated with risk of STI and HIV
diagnosis and predictors for PrEP use. The aims of this proposal are to: 1) refine the HealthMpowerment
(HMP) digital platform, previously utilized to deliver evidence-based interventions to improve HIV and
prevention outcomes among Black men who have sex with men and transgender women, to include key
elements that optimally engage and retain a cohort of women at-risk for HIV in AL; this will be achieved via
stakeholder engaged research with self-identified women on PrEP and PrEP care team members using
nominal group techniques; 2) recruit and retain a geographically-diverse and rurally-enhanced cohort of 800
women ages 18-44, with recent positive gonorrhea or syphilis testing who are STI- and HIV-uninfected at
enrollment, to participate in the Camellia digital cohort utilizing a geographically diverse sampling framework
using public and commercially available annual county-level HIV and STI testing data and 3) evaluate
predictors, mediators and moderators for STI/HIV incidence and PrEP use and adherence in the Camellia
Cohort by collecting demographic, behavioral, and community level assessments via the HMP digital platform
and HIV/STI testing through ADPH’s home testing program at regular intervals; we will purposefully sample
women with high HIV vulnerability and/or PrEP use within the cohort for in-depth interviews (n = 30) to further
explore factors contributing to PrEP use to guide future intervention development. This research will lay the
groundwork for a larger research program testing the implementation of a further adapted HMP digital platform
designed to improve HIV/STI testing, PrEP utilization and persistence among women in the Deep South,
focusing on areas with higher HIV incidence.

Public health relevance
Narrative The proposed project seeks to determine best practices for recruiting and engaging women living in the Deep South who are vulnerable to HIV infection into a digital cohort, with the goal of evaluating factors that contribute to STI and HIV infection and HIV pre-exposure prophylaxis use. Outcomes from this study will help identify gaps in Ending the HIV Epidemic initiatives in reaching Southern women at highest risk for acquiring HIV and guide future intervention development. This project is responsive to national priorities outlined by the Ending the HIV Epidemic initiative as well as the National Institute of Allergy and Infectious Diseases AWARE funding opportunity announcement.